Fis1 Regulation of Mitochondrial Fission

Project Summary/Abstract
Altered division, or fission, of mitochondria has severe consequences even death. Yet the reasons for this
are unknown. It is postulated that the mitochondria have their own lifecycle that involves fission of unhealthy
mitochondria to remove them in an autophagic process called mitophagy. These quality control processes are
evolutionarily conserved between budding yeast and humans, although extent to which has recently been
called into question. In yeast, fission requires the protein FIS1 that is now thought to be dispensable for fission
in mammals, but indispensable for mitophagy. Consistent with this view are FIS1 interactions in mitophagy
human cell culture. Contrary to this view, loss of FIS1 elongates mitochondrial and displaces the fission
mechanoenzyme DRP1 from mitochondria in some, but not all, cell types. Mutations to some evolutionarily
conserved residues in FIS1 impair fission and DRP1 localization. Mutations to different conserved residues
impair binding to a critical adaptor in mitophagy, the Rab7 GTPase Activating Proteins TBC1D15 and
TBC1D17. These findings suggest that FIS1 is conserved for roles in both fission and mitophagy. Using yeast-
inspired mutations, along with state-of-the-art genetic, microscopic, and structural tools, we are now poised to
determine how conserved components govern the fate of mitochondria between fission, mitophagy, or
apoptosis. To understand the protein-protein interactions that govern this, biochemical and structural studies
will be integrated with state-of-the-art cell biological and genetic approaches. A better understanding of the
protein machinery and how it works will identify key points of regulation that may be targeted in future studies
with small molecules to inhibitor, and activate fission, mitophagy, and apoptosis. The discovery of such
molecules may ultimately lead to treatments for diseases in which enhanced, or impaired, fission activity is
central.

Public health relevance
Project Narrative Mitochondria are components of cells that perform many functions critical for life and are known for being the "power plant" of the cells. The mitochondria have their own life cycle with a mechanism to destroy damaged mitochondria that involves a splitting event that separates a healthy daughter mitochondrion from an unhealthy one that is subsequently removed by the cell. The work proposed will illuminate mechanistic details of these processes and represents an important step towards the discovery of new therapeutic strategies for both rare and common human diseases, including cardiac and neurodegenerative diseases, cancer, diabetes, aging, and neonatal lethality syndrome.